BLRD Research Career Scientist Award Application

Project Summary/Abstract
This application requests the appointment of Dr. Wendy Bollag, a Research Physiologist at the Charlie
Norwood VA Medical Center in Augusta, Georgia and a Professor of Physiology at the affiliate institution
(Augusta University), to the position of Research Career Scientist. In the past five years, Dr. Bollag has been
productive, publishing 29 peer-reviewed articles and more than 10 invited reviews, book chapters and
commentaries, with 52 peer-reviewed articles and 26 invited reviews, book chapters and commentaries in the
past 10 years. Dr. Bollag’s research in cell signaling seeks to understand the role of particular signaling
molecules in various cell processes; this research has led to interesting findings in her systems of interest,
keratinocytes of the skin epidermis and zona glomerulosa cells of the adrenal gland, as well as extension of this
knowledge to collaborative projects in other systems, including corneal wound healing. In the case of the skin
and the adrenal gland, Dr. Bollag is interested in determining the signaling pathways that underlie keratinocyte
proliferation and differentiation to form the epidermis under normal and pathological conditions, as well as those
that regulate aldosterone production in the adrenal zona glomerulosa. In the past 10 years the Bollag laboratory
has made significant progress in projects examining these two processes, as evidenced by the many publications
for which she is the senior author. Dr. Bollag has also received as Principal Investigator (PI) or Co-PI three
National Institutes of Health (NIH) R01 awards, one R29 award and one R21 award, five VA Merit Awards (three
to support her work in skin, one to fund studies in the adrenal gland and one to support a new study in the
cornea), a VA Research Career Scientist Award, two VA Shared Equipment Evaluation Program (ShEEP)
awards and multiple state and intramural grant awards. She also recently received, as Contact Co-PI, an NIH
T35 training award (with Co-PI, Dr. Carlos Isales) to recruit medical students from three Puerto Rican medical
schools to perform summer aging research. She has also served as a Co-Investigator on several awards,
including an NIH P01 Program Project Award with her colleague and collaborator of approximately 35 years, Dr.
Isales, and as the Lead Mentor on a Department of Defense mentoring partnership award to Albany State
University. Last year she received the Augusta University Research Institute Distinguished Investigator Award;
she was also invited to give a symposium presentation at the 2019 annual meeting of Experimental Biology. This
year she was invited to present in the Blank Forum at the 2020 annual meeting of the Society for Investigative
Dermatology (which was unfortunately cancelled due to the pandemic) and to give a named lecture at the
Oklahoma Center of Neuroscience (postponed until 2021 because of COVID-19), indicating that she is
recognized for her research. Finally, Dr. Bollag is an individual who is engaged with the community and involved
in giving back in service at the institutional, local and national levels. Thus, she mentors junior colleagues,
including Dr. Debra Irsik, a recent VA Career Development Award recipient, provides educational service to the
affiliate institution (for which she has received numerous awards), serves as a reviewer for multiple journals and
participates in review panels for several national and international funding agencies, including the VA. Currently,
Dr. Bollag is an Editorial Consultant for the Journal of Investigative Dermatology, the highest impact journal in
the field of dermatology research, a Senior Editor for the Journal of Endocrinology and the Journal of Molecular
Endocrinology and a member of the editorial boards of the Journal of Lipid Research and Molecular
Pharmacology. Thus, Dr. Bollag is an established investigator and a recognized mentor, who would adeptly fulfill
the responsibilities of the Research Career Scientist designation.

Public health relevance
Project Narrative This application requests the appointment of Dr. Wendy Bollag, Research Physiologist at the Charlie Norwood VA Medical Center (CNVAMC) and Professor of Physiology at the affiliate Augusta University, to the position of Research Career Scientist. Dr. Bollag investigates signaling mechanisms that regulate cell responses in multiple systems. One such response is skin cell growth and maturation to form the outer layer of skin and another is corneal wound healing; these processes seem to be mediated by similar signaling mechanisms. This research has relevance to corneal injury, for which combat soldiers are at high risk, as well as non-melanoma skin cancer, with about 3 million new cases annually in the US, and psoriasis, a common skin disorder affecting an estimated 400,000 veterans. Another project examines the signals regulating adrenal gland production of aldosterone, a hormone involved in salt retention and blood pressure control. Excessive secretion of aldosterone results in hypertension, which affects almost 3.5 million veterans and approximately two-thirds of patients at the CNVAMC.